IdeNtifying reSponse defIninG mecHanisms for biological TherapieS in SevereAsthma (INSIGHTS ); assessing the role of CD4-CTLs

PROJECT SUMMARY
Severe asthma, characterized by persistent airway inflammation and corticosteroid resistance, afflicts millions of
Americans with limited therapeutic options. Clinicians currently rely on Type 2 immune biomarkers for patient
classification (T2HIGH vs. T2LOW) and treatment decisions. However, real-world studies revealed the over-
representation of the T2HIGH endotype in severe asthma and those treated with anti-T2 biologic therapies exhibit
contrasting responses, challenging the efficacy of this T2 dichotomy and highlighting the need to explore
alternative pathophysiological drivers.
Our single-cell transcriptome analysis of T cells from inflamed airways in severe asthmatics identified a novel
subset of pathogenic airway tissue resident cytotoxic CD4+ T cells (CD4-CTLs). Despite biologic treatment, CD4-
CTLs remained activated, producing inflammatory molecules. Cell proportions analysis linked CD4-CTLs to
asthma severity and lung function impairment, particularly in males with late-onset asthma. The study strongly
supports CD4-CTLs' significant contribution to airway inflammation, potentially hindering T2-biologic response.
Led by a multidisciplinary team of experts in clinical asthma, and immuno-genomics, Drs. Kurukulaaratchy and
Seumois, our INSIGHTS study aims to assess the impact of CD4-CTLs on severe asthma pathogenesis and T2-
biologics response at a larger scale.
AIM 1: We will analyze airway CD4-CTLs from blood and sputum samples collected from 160 severe asthmatic
patients before, and 12- and 24- months after initiating T2-biologic therapy. We will evaluate the impact of CD4-
CTLs on T2-biologics response through extensive clinical analysis. Samples will be collected by three clinical
centers [University of Southampton, UK; University of Michigan, Ann Arbor, US, and University of California, San
Diego, US] establishing the clinical significance of CD4-CTL as a new player in asthma pathogenesis.
AIM 2: With the planned collection of samples, we will generate up to 1 million single-CD4-CTL cell
transcriptomes allowing us to comprehensively decipher the pathogenic cellular and molecular features of CD4-
CTLs in asthma severity and response to T2-biologics, as well as investigate their function through TCR-
reactivity and interactions with structural cells analysis.
In summary, this unique translational proposal aims to unveil mechanisms causing a lack or loss of response to
T2-biologics in severe asthma, focusing on CD4-CTLs. Findings could establish CD4-CTLs as a better predictor
for patient stratification, leading to novel therapies for unmet patient needs.

Public health relevance
PROJECT NARRATIVE Severe asthma, a persistent airway condition affecting millions of Americans, with no cure, relies on simplistically defined Type 2 biomarker status for treatment decisions. New T2-targeting biologic therapies showed contrasting patient responses questioning an oversimplified T2-assessment as an efficient therapy response predictor. Our prior research revealed an unknown population of pathogenic CD4 cytotoxic T cells (CD4-CTLs) in airways of severe asthmatics that are associated with disease severity. The proposed INSIGHTS study, led by a multidisciplinary team, aims to comprehensively investigate CD4-CTLs impact on T2-biologics responses at clinical (AIM1) and molecular levels (AIM2). Utilizing advanced genomic tools, we also plan to further understand CD4-CTLs' biology (AIM2). This research aims to expand our understanding of severe asthma, potentially guiding development of more effective treatments.